Generation of tools for visualizing understudied KvS potassium channel proteins

Abstract
Voltage-gated ion channels are modulated by many existing drugs and the targets of pharmaceutical
development programs to treat a diverse array of maladies. A major obstacle to developing ion channel drugs is
identification and validation of molecular targets that ameliorate disorders while limiting side effects. Recently,
transcriptomics projects have identified transcripts for KvS voltage-gated K+ channels in somatosensory and
motor neuron subtypes, suggesting that studying these KvS subunits could potentially identify strategies to
ameliorate neuropathic pain or motor dysfunctions. KvS proteins are voltage-gated K+ channel subunits which
are “electrically silent” unless they coassemble with voltage-gated K+ channel subunits of the Kv2 family. The
function of many KvS subunits and their role in disease remains largely unexplored, however, as there are few
or no research tools for these subunits. The Illuminating the Druggable Genome program has appropriately
identified several KvS family members as “understudied” including KCNG2-4 (encoding Kv6.2-6.4) and KCNS1
(encoding Kv9.1). Gene expression studies show that these KvS subunits are robustly expressed in select spinal
cord and dorsal root ganglia neurons where their participation in electrical signaling would be expected to
influence movement, proprioception, and pain. However, there is little information available on the expression of
these KvS subunits at the protein level due to a lack of well-validated reagents for their detection in native tissue.
The objectives of this project are (i) to develop specific monoclonal antibody and genetically-encoded
tools to visualize understudied KvS subunits, and (ii) to use these reagents to define the cellular and
subcellular localization of KvS subunits in spinal cord and dorsal root ganglia neurons. These tools and
information on where Kv2/KvS heterotetrameric channels are expressed will provide an essential platform for
further studies on the physiological role of KvS subunits and their role in neurological disorders and potential
utility as drug targets. This research could potentially identify specific KvS subunits as selective drug targets for
the treatment of motor and sensory neuron disorders, including excitotoxicity in amyotrophic lateral sclerosis,
and hypersensitivity in neuropathic pain.

Public health relevance
The work will develop critical tools to visualize several understudied KvS “electrically silent” potassium channel subunits that are expressed in specific neuronal subpopulations. These tools will be used to define where KvS subunit proteins are expressed in spinal cord and DRG, to study their potential utility as drug targets for the treatment of motor and sensory neuron disorders.